PRA-Chicago Transplant Insight Study

DESCRIPTION (Provided by the Applicant): This application uses probabilistic risk assessment (PRA) to estimate the frequency of transplant donor/recipient mismatches. PRA has proven useful to understanding other complex work system domains, such as nuclear power plants, but its application in this area of health care is novel. The goal of this study will be to use PRA to mitigate risks associated with transplant mismatches, and more broadly, to determine how this process may be extrapolated to other areas of health care and contribute to improved patient safety. To this end, the following specific aims are proposed: Specific aim 1: Produce a probabilistic risk assessment of transplant donor/recipient mismatch. Specific aim 2: Evaluate the sensitivity of the resulting probabilistic risk assessment to contingent event probability and model changes. Specific aim 3: Characterize the transplant donor/recipient mismatch assessment. Specific aim 4: Identify improvements that could reduce the risk of recipient/donor mismatch. Specific aim 5: Evaluate the risk assessment results and possible process and condition changes. The PRA model will be developed through extensive field analysis of the work of transplants. The principal investigator will provide opportunities for collaboration among all staff typically involved in transplants, and the subcontractor, who has more than 25 years experience in use of PRA, will provide all direction regarding PRA model development. Dissemination of results and project evaluation will be accomplished through stakeholder workshops.